National Capital Area (NCA) NCI Community Oncology Research Program (NCORP)

The NCA NCORP (funding support from 5UG1CA239758-06) is based at Georgetown Lombardi Comprehensive Cancer Center (LCCC), and consists of Medstar Georgetown University Hospital (MGUH) and MedStar Washington Hospital Center (MWHC) as the primary affiliate, with a catchment area comprising 58.9% understudied populations within Washington, D.C. and adjacent counties in Maryland and Virginia. Cancer burden is greatest among representative populations in our catchment area as evident by some of the highest mortality rates in the nation for breast, prostate, and colorectal cancers. The NCA NCORP proposes to address one of the most significant factors associated with this variance in cancer burden - limited access to optimal and cutting-edge prevention, cancer control, and cancer care delivery by increasing awareness and providing access to cancer clinical trials. LCCC’s Office of Health Disparities Research, represents the community outreach arm that is led by Dr. Adams-Campbell, that has established viable academic-community partnerships that enable the NCA NCORP to conduct clinical research in areas of prevention, control, screening, health variance, and cancer care delivery among the representative populations of interest. In light of an aging population and the increasing number of cancer survivors, this NCORP has the expertise and leadership as evident by demonstrable research in these areas that address cancer control and patient centered cancer care delivery. Furthermore, the ability to address cancer prevention and control among adolescents and young adults (AYA) is also a key strength of our team. The NCA NCORP will address the needs of our catchment area via cancer prevention, control, screening as well as treatment and imaging studies.

Public health relevance
The National Capital Area (NCA) NCORP, based at Georgetown Lombardi Comprehensive Cancer Center (LCCC) and comprised of MedStar Georgetown University Hospital (MGUH) and MedStar Washington Hospital Center (MWHC), will conduct cancer clinical research towards efforts to reduce cancer-related variances and health care outcomes. The NCA NCORP will address the needs of our catchment area via cancer prevention, control, screening as well as treatment and imaging studies.